GENERAL SOFTWARE SUPPORT - LHNCBC

This acquisition will provide computer programming, systems design and related technical software development in support of intramural research and development within the Lister Hill National Center for Biomedical Communications at the National Library of Medicine.